Cardiometabolic disease and vascular aging: Klotho regulation of medial arterial calcification

Project Summary/Abstract
Peripheral artery disease (PAD) is a public health crisis, affecting 20 million Americans and 200 million people
worldwide, and continues to grow due to aging and the epidemic rise of diabetes and renal metabolic
disorders. Vascular calcification (VC) is accelerated in these conditions, particularly in a distal pattern of medial
artery calcification (MAC) in the lower leg and foot. In chronic limb-threatening ischemia (CLTI) — the most
advanced form of PAD — we have shown that MAC poses a significant challenge to lower extremity
revascularization and is a major risk factor for limb amputation. However, there remains no effective treatment
for VC, and both the pathologic characteristics and mechanistic drivers of MAC in PAD are poorly understood.
Emerging data suggest that Klotho — a regulator of insulin signaling and phosphate homeostasis — is lost in
diabetes and renal disease, which may play an important role in osteogenic pathways promoting MAC. We
hypothesize that Klotho is a central regulator in the pathogenesis of MAC, and its loss under conditions of
hyperglycemia, hyperphosphatemia and low shear stress promotes VSMC osteogenic transdifferentiation and
VC. This hypothesis will be rigorously investigated via two innovative and complementary central aims:
Aim 1 takes a clinically-oriented approach to define molecular and cellular calcific changes occurring in the
serum and vasculature of patients with CLTI. Pedal artery tissue and serum samples from patients with CLTI
will be analyzed, focusing on the relationship between Klotho arterial tissue expression, serum Klotho levels,
clinical pedal artery calcium burden (pMAC score), and VSMC phenotype. Aim 2 approaches the hypothesis
from a basic science angle, using 3D human engineered vessels in culture to characterize de novo molecular
alterations occurring in response to conditions of hyperglycemia, hyperphosphatemia and low shear stress.
I will carry out this work with the close support of my mentors Dr. Michael Conte, an accomplished vascular
surgeon-scientist and global leader in the field of PAD, as well as Dr. Matthew Kutys, who is an expert in state-
of-the-art microfluidics and 3D vascular modeling. Both the Conte and Kutys labs are embedded within the rich
UCSF research environment and provide access to the resources needed to execute my project.
This investigation builds upon my career goal to become a vascular surgeon-scientist focused on the field of
vascular calcification — a highly impactful area that remains a critical barrier to improving clinical outcomes in
PAD. My prior research has laid important groundwork in this area, quantifying the problem of pedal artery
calcification and establishing its impact on outcomes in CLTI. The proposed work provides an innovative
opportunity to develop my unique investigator profile by delving translationally into the mechanisms governing
MAC, leveraging the expertise of my mentors and my background in MAC clinical research and 3D tissue
culture. The overarching objective of this fellowship will be to grow my technical skill set and topic expertise,
while providing important advancements to identify potential targets for therapy.

Public health relevance
Project Narrative Vascular degenerative disease has emerged as one the most important modern public health crises facing our aging population, in which the epidemic rise of diabetes and renal disease has resulted in an unprecedented burden of cardiovascular morbidity and mortality. In chronic limb-threatening ischemia (CLTI) — the most severe form of peripheral artery disease — diabetic and renal metabolic syndromes have shifted the pattern of disease toward the smaller vessels of the leg and foot, in which progressive calcification replaces the normal contractile arterial media, obliterates vascular outflow and renders standard therapies ineffective, ultimately resulting in high rates of treatment failure and limb amputation. The proposed research plan will provide crucial insight into the pro-calcific molecular and cellular alterations that occur under conditions of hemodynamic and metabolic stress in CLTI, focusing on the role of the anti-aging gene Klotho as a key regulator of arterial calcification — ultimately with the goal of identifying therapeutic targets to prevent or reverse vascular calcification and improve both human longevity and quality of life.